Elucidating the biological mechanisms underlying the association between EBV and MS in African Americans

PROJECT SUMMARY: Despite progress in treatment, multiple sclerosis (MS) continues to be a chronic
progressive disease with a high personal and societal impact, and its incidence has been increasing over the
past few decades, particularly in women and in African Americans. The recent discovery that the Epstein-Barr
virus (EBV) is the leading cause of MS has spurred interest in the immunology of EBV infection and on the cross-
reactivity of anti-EBV antibodies with autoantigens as a potential pathogenic mechanism for MS (molecular
mimicry), and has raised the expectation that MS could be prevented by an EBV vaccine. Most previous
investigations of the molecular mimicry hypothesis, however, have been restricted to whites of European
ancestry and their results cannot therefore be generalized to Blacks, who have experienced a marked increase
in MS incidence over the past few decades, have more severe MS, and are infected with EBV and other viruses
at younger ages than whites. We propose therefore to conduct a longitudinal study among African Americans,
using blood samples collected years before the onset of MS to determine whether EBV-induced molecular
mimicry is a likely cause of MS. The study will rely on the data and serum samples prospectively collected from
over 10 million individuals in active duty in the U.S. military. During the past 20 years, in collaboration with military
investigators, we have reviewed the medical records of all members of this population diagnosed with MS while
on active duty, confirmed the MS diagnoses according to research criteria, and obtained pre-diagnostic serum
samples (up to three per person) from all cases and matched controls. At this time, we have clinical data and
pre-diagnostic serum samples from 395 black individuals who developed MS and 395 controls matched by race,
sex, age, dates of blood collection, and branch of the military. For the proposed project, we will include 240 black
men and 240 black women. The project will rely on a set of novel platforms to profile antibody responses.
Selected sera will be assessed for antibodies against the entire human virome and human proteome using the
Nucleic Acid Programmable Protein Array, GlialCAM peptides, and glycosylated EBV proteins, which carry the
epitopes targeted in vaccine development. In addition to the role of molecular mimicry, we will also address the
following questions: i) is it possible to leverage the humoral immune response to the human virome and proteome
to identify those apparently healthy individuals who will later develop MS? and ii) to which extent the humoral
immunity to cytomegalovirus and other human viruses affects the risk of MS? Answer to these questions would
have transcending implications for MS prevention, because only about 1 in 400 EBV infected individuals will ever
develop MS. If these individuals were identified before the disease onset, it may be possible to modify their
immune response to EBV with a vaccine or antiviral in a manner that reduces their MS risk. The proposed project
will contribute to bridge the widening gap that exists about what we know on the causes of MS among whites
and Blacks, and will strengthen our ability to identify and treat MS in its earliest stages.

Public health relevance
NARRATIVE There is compelling evidence that multiple sclerosis (MS), one of the most common disabling neurological diseases in young adults, is a rare complication of infection with the Epstein-Barr virus (EBV). Purpose of this project is to contribute to elucidate the mechanisms by which EBV causes MS, and to determine whether measurement of antibodies in blood of apparently healthy young black men and women will allow the early identification of those who will develop MS. Our project will contribute to bridge the widening gap between Blacks and whites in research on the prevention and early treatment of MS, to identify MS before the onset of clinical symptoms, and ultimately to reduce the disability associated with this uncurable disease.